Immunogenomics and Systems Biology Core

ABSTRACT
The Immunogenomics and Systems Biology Core (ISCB) at University of Michigan will support the data analytics,
management, and disease translation to meet the goals of the entire AMP AIM Network. The ISCB will be based
on our extensive experience in the development of genetics and systems biology approaches, working with a
broad range of multi-omics data including genetic, epigenetic, single-cell and spatial-seq data, to increase our
understanding of the factors that contribute to disease pathogenesis and heterogeneity. The premise of our
approach is that integrating genetic information with other -omic data, collected through the AMP AIM Network,
will facilitate and accelerate discovery of critical pathogenic mechanisms and help unravel the biologic processes
contributing to disease heterogeneity. This approach will utilize advanced analytical approaches in causal
mechanism inference, modeling and single cell and spatial genomics data integration. To achieve this we will i)
deploy highly customized, scalable, and robust data processing capabilities and standardized pipelines for
curation, processing, management, and sharing of multi-omics and integrated clinical datasets; ii) build
comprehensive disease specific roadmaps, and define shared and unique molecular mechanisms of AMP AIM
target diseases utilizing statistical genetics and genomics approaches; iii) identify, characterize, and refine
biomarkers shaping disease heterogeneity and intervention response by integrating multi-omics and clinical data
through statistical and computational modeling.

Public health relevance
NARRATIVE The Immunogenomics and Systems Biology Core (ISBC) at University of Michigan will provide the technical and analytic support for the entire AMP AIM network. The ISBC will expand cutting-edge analytical technologies, that we have developed, to conduct systems-level analyzes of the broad range of multi-omics data generated in the AMP AIM, and link with genetic information, to facilitate identification of molecular disease determinants at the cellular level, determine their roles in shaping inflammatory signaling, disease heterogeneity, and treatment response.